Proteostasis dysregulation and alpha-synuclein

Accumulation of alpha-synuclein (αSyn) causes degeneration of dopaminergic (DA) and non-DA neurons in Parkinson’s disease (PD) and Dementia with Lewy Bodies (DLB). αSyn also contributes to the fibrilization of
amyloid-β and tau, two key proteins in Alzheimer’s disease (AD), which suggests a key role for αSyn toxicity in
neurodegeneration. Thus, it is important to elucidate downstream effects and the factors promoting the toxic
conversion of αSyn, towards understanding the pathogenesis of and developing disease-modifying therapies for synucleinopathies. In PD and DLB, pathological αSyn proteins enrich in mitochondria of vulnerable brain regions, where to induce mitochondrial bioenergetic defects and production of reactive oxygen species. Despite evidence suggests that αSyn-mitochondrial interactions may play a causal role in PD and DLB, the field lacks a detailed understanding of the mechanisms by which αSyn abnormality and mitochondrial functional deficiency influence each other. To maintain normal mitochondrial health and function, cells employ a mitochondria-to-nucleus signaling pathway termed the mitochondrial unfolded protein response (UPRmt). The UPRmt monitors mitochondrial proteostasis through mitochondrial specific proteases and molecular chaperones, which facilitate folding and/or degradation of unfolded proteins within mitochondria. They also communicate with the nucleus by retrograde signaling to activate the expression of peptide-folding related proteins. The UPRmt is an important defense mechanism for maintaining the quality of proteins within the mitochondria under stress. Defects in UPRmt have been linked to aging and neurodegeneration. Our recent work showed, for the first time, that the protein level of ClpP, a mitochondrial matrix protease induced during UPRmt activation, was decreased in neurons expressing αSyn wildtype (WT) or A53T mutant, in brains of mice carrying A53T mutant, and in the Substantia Nigra of PD patients. The mRNA level of ClpP remained unchanged, suggesting a transcriptional independent effect. Preliminary study further found that the protein level of ClpP and not other mitochondrial proteases, decreased in the cortex of patients with DLB and mice expressing human Thy1-αSyn. These results suggest that a decrease in ClpP is a common event implicated in the pathogenesis of both PD and DLB. Whereas silencing ClpP in neurons increased a load of unfolded proteins in the mitochondria,
reduced mitochondrial bioenergetic activity and increased cell death; overexpressing ClpP abolished αSyn-induced oxidative stress in cultured cells, and attenuated αSyn hyper-phosphorylation and behavioral abnormality in αSyn A53T mice. Notably, we found that αSyn bound to ClpP and suppressed ClpP peptidase activity, whereas genetic manipulation of ClpP influenced the assembly of non-toxic αSyn tetramers that resist aggregation. Thus, our pilot findings highlight a previously unidentified interdependence between pathological αSyn and mitochondrial protease ClpP, which results in a disturbance of mitochondrial proteostasis, leading to neuronal damage. Given that αSyn accumulation is a common pathological hallmark of both PD and DLB, the goal of this study is to determine the role of ClpP-mediated mitochondrial proteostasis in PD and DLB at both mechanistic and therapeutic level. Built on our study supported by the NIH bridge award R56 NS105632-1A1, we will test the central hypothesis that pathological αSyn disturbs mitochondrial proteostasis by suppressing ClpP and UPRmt, which impairs mitochondrial bioenergetic activity and promotes the toxic conversion of αSyn, leading to αSyn neuropathology. Our research team has the unique synergistic expertise in UPRmt, mitochondrial biology, and αSyn neuropathology required to impact this significant area of unmet medical need. Successful completion of the proposed study will not only contribute to the basic understanding of disease pathogenesis, but it will also aid in the development of treatments for PD and DLB and even other neurodegenerative diseases in which αSyn aggregation manifests.

Public health relevance
α-Synuclein aggregation is the pathological hallmark in both Parkinson's disease (PD) and Dementia of Lewy Bodies (DLB). The proposed study seeks to better understand the molecular mechanisms by which α-Synuclein causes dysregulation of mitochondrial protein homeostasis, and to reveal novel targets for developing therapeutics to treat PD and DLB.